CHIcago Center for Accelerating nextGen Omics, deep phenotyping, and data science in Heart Failure (CHICAGO-HF)

ABSTRACT
This application proposing the CHIcago Center for Accelerating nextGen Omics, deep phenotyping, and
data science in Heart Failure (CHICAGO-HF) is in response to the RFA “HeartShare: Next-Generation
Phenomics to Define Heart Failure Subtypes and Treatment Targets-Clinical Centers.” Heart failure with
preserved ejection fraction (HFpEF) is associated with significant morbidity and mortality and is increasing in
prevalence. No effective disease-modifying therapies exist for patients with HFpEF, largely due to the
substantial heterogeneity among patients with HFpEF for whom the current “one-size-fits-all” treatment
paradigm is failing. A large-scale, multicenter observational study to conduct deep phenotyping in patients with
HFpEF is a critical next step to advance our understanding of HFpEF pathophysiology and shift our clinical and
research paradigm in HFpEF towards a precision medicine approach. We propose three central elements that
are critical to address to comprehensively phenotype patients across the spectrum of HFpEF. First, direct
phenotyping of the myocardium, using tools such as magnetic resonance imaging (MRI) and endomyocardial
biopsy, is necessary to elucidate the intrinsic myocardial biology of HFpEF. Second, detailed phenotyping of
the complex interplay of extra-cardiac comorbidities is needed to better understand the systemic nature of
HFpEF. Third, a representative sample of HFpEF patients with diversity across sex, race/ethnicity, geography,
and socioeconomic status needs to be included in phenotyping efforts to prevent widening of well-documented
disparities in HFpEF. The proposed Clinical Center, CHICAGO-HF, led by Northwestern, is uniquely qualified
to participate in all aspects of the HeartShare Network and to substantially enhance the Network’s goals. In our
application, we demonstrate key prior experiences, which include: (1) development of the world’s first
dedicated clinical program in HFpEF; (2) recruitment of large numbers of patients with HFpEF into multicenter
observational studies and trials; and (3) participation as a Field Center for NHLBI-funded cohorts. Our well-
resourced multi-disciplinary investigative team has expertise in epidemiology, informatics, deep phenotyping,
and artificial intelligence. We will leverage our experiences with our robust electronic health record
infrastructure to efficiently collect, harmonize and share retrospective and prospective data on a large number
of diverse patients with HFpEF and age- and sex-matched controls (HF with reduced and mid-range EF and
healthy controls). We will prospectively recruit at least 250 patients within the study timeline with community
partners across Chicago (e.g. Federally Qualified Health Centers). In addition, our unique expertise in
innovative MRI techniques and data analytics can strengthen the Network and will enable testing of significant
and innovative hypotheses to define unique phenotypes, elucidate distinct endotypes that represent underlying
pathobiology, and identify novel targeted therapeutics for HFpEF. CHICAGO-HF is ideally suited to serve as a
Clinical Center and contribute to the Network’s long-term mission to equitably improve HFpEF outcomes.

Public health relevance
NARRATIVE This project is relevant to public health because we will collaborate with the NHLBI and the HeartShare Network to generate new knowledge regarding unique subtypes of heart failure with preserved ejection fraction and underlying mechanisms to ultimately improve patient outcomes. Specifically, the CHIcago Center for Accelerating nextGen Omics, deep phenotyping, and data science in Heart Failure (CHICAGO-HF) proposes to contribute to the development of retrospective and prospective cohorts of patients with heart failure with preserved ejection fraction and controls. We aim to strengthen the Network through our considerable experience and expertise in epidemiology, informatics, magnetic resonance imaging, and artificial intelligence.